NU-TRIHO (Northwestern University Translational Research in Hematology-Oncology) Training Program

Project Summary
This revised proposal seeks funding for the Northwestern University-Translational Research in Hematology-
Oncology (NU-TRIHO) Training Program, prompted by the urgent need for clinician-scientists in Hematology-
Oncology who are highly motivated and well-prepared to launch and succeed in careers that combine clinical
practice and translational research. The objective of this program is to prepare trainees for the challenges
awaiting the next generation of academic oncologist-researchers. It will provide educational and research
experiences that integrate and bridge basic and clinical sciences, thereby establishing a solid foundation for
translational research. It will confer skills that will complement their educational and research experiences and
prepare them for careers in academia. It will implement an intensive career development program that will
provide information, counseling, and assistance to help each trainee navigate the challenges faced in
establishing a successful translational research career. Trainees will be appointed for two years after completing
one year of clinical training in the Northwestern University Medicine or Pediatric Hematology-Oncology
Fellowship programs. Seventeen laboratory preceptors have been selected as program faculty based on their
research focus, funding, and mentoring expertise and capabilities. Seventeen clinical preceptors, who have
successful track records in clinical research and collaborate with many of the laboratory preceptors, have been
selected to facilitate translational efforts, provide career advice, and participate in mentoring research
committees. The curriculum, which will be individually tailored to each trainee, consists of mentored laboratory
and clinical research, exercises to refine communication and grant writing skills, guided readings and
discussions, formal training in clinical design and conduct, training in the responsible conduct of research as well
as rigor and reproducibility, and career development activities that complement the trainees’ laboratory and
clinical investigations. The career development component will provide information, counseling, and assistance
to help each trainee navigate the challenges that arise while establishing a successful independent translational
research career. Multiple mechanisms are in place to evaluate the performance and success of the NU-TRIHO
Training Program. The Program has strong institutional support from the Lurie Cancer Center and the Feinberg
School of Medicine’s Departments of Medicine and Pediatrics. The proposed NU-TRIHO Training Program
responds to the challenges faced by the next generation of academic hematologists and medical oncologists
and addresses the critical need for more such individuals who are well-versed in clinically relevant basic science
research, translational research, and clinical trial design.

Public health relevance
Project Narrative The NU-TRIHO Training Program is designed to train academically oriented Medicine and Pediatric Hematology- Oncology fellows at Northwestern University to become successful translational researchers. It integrates an educational curriculum and a career development program with laboratory and clinical research training to prepare trainees for careers in academic medicine. A group of highly qualified laboratory and clinical preceptors will provide guidance and mentorship to the trainees in the NU-TRIHO Training Program.